Efficacy of the Improving Participation after Stroke Self-Management-Rehabilitation (IPASS-R) program in sub-acute stroke

Project Summary/Abstract
The long-term goal of this research is to improve self-efficacy, activity performance, and health in
individuals with stroke. Current stroke rehabilitation research and practice must be addressed to shift the focus
of the field from an over-emphasis on impairment reduction to management of stroke as a chronic disease.
The overall hypothesis of this proposal is that a clinically feasible, self-management-based intervention, the
Improving Participation after Stroke Self-Management Rehabilitation (IPASS-R) program, will produce a
significant improvement on measures of self-efficacy, activity performance, quality of life, and community
engagement outcomes as compared to a general health-focused self-management program, the Chronic
Disease Self-Management Program (CDSMP). All assessment and intervention procedures will be conducted
virtually via videoconferencing. The specific aims of this project in the subacute stroke population are to: (1)
evaluate the efficacy of IPASS-R to improve self-efficacy within home, community, and work activity
performance; (2) evaluate the efficacy of IPASS-R to improve activity performance and quality of life; and (3)
explore the effect of IPASS-R on objective measures of in-home activity patterns and community engagement.
Participants with subacute stroke living in the community will be recruited through local hospitals at two sites (n
= 100). Those individuals who meet eligibility criteria will be randomized to either an IPASS-R group or to a
CDSMP group. Both groups will receive six, 90-minute group sessions of self-management education.
Treatment outcomes will be assessed at baseline, post-intervention, and at six-months post-intervention.
Treatment efficacy outcomes will be analyzed with an intent-to-treat model with an analysis of covariance
(ANCOVA). Potential covariates will include age, stroke severity, degree of cognitive impairment, and degree
of motor impairment. Independent samples t-test and chi-square test will be used to ensure successful
randomization and balance between groups. Group differences at baseline that are statistically significant will
also be considered as covariates in the analysis. Post-hoc tests will be employed as appropriate. Significance
levels, effect sizes, and confidence intervals will be reported. Completion of this study is likely to result in an
efficacious, clinically feasible intervention to improve self-efficacy, activity performance, and participation in
individuals with stroke that can be feasibly implemented into current systems of care. The proposed study and
anticipated outcomes are consistent with the research priorities of the National Center for Medical
Rehabilitation Research (NCMRR), which include which include rehabilitation interventions focused on chronic
symptom management with real-world, participatory outcomes and objective markers of functional progress.

Public health relevance
Project Narrative Stroke rehabilitation is primarily focused on reduction of stroke-related impairments, e.g., motor impairment, with the intention that impairment reduction will lead to improved ability to participate in everyday life activities, e.g., self-care, work. Despite substantial research to investigate the use of these impairment- reduction approaches in stroke, there is limited evidence to support that these approaches result in any meaningful impairment reduction that translates to improved ability to perform everyday life activities. This proposal seeks to evaluate if a stroke-rehabilitation self-management program, that targets management of chronic stroke symptoms rather than impairment reduction, can improve self-efficacy, activity performance, and quality of life in individuals with sub-acute stroke.